A multi-modal, physician-centered intervention to improve guideline-concordant prostate cancer imaging

Background: Almost half of Veterans with localized prostate cancer (the most common non-cutaneous
malignancy among US men) receive inappropriate, wasteful imaging. The VHA Blueprint for Excellence
prioritizes increasing operational effectiveness. Prior studies seeking to limit inappropriate imaging did not assess
barriers and achieved mixed results. Our team has explored the causes of guideline-discordant prostate cancer
imaging and found that 1) patients with newly diagnosed prostate cancer have little concern for radiographic
staging but rather focus on treatment, 2) physician trust imaging guidelines but are apt to follow their own intuition,
fear medico-legal consequences, and succumb to influence from colleagues who image frequently. In spite of
such discrepant v iews, most VHA physicians suggested or supported a large-scale effort to improve imaging use
across VHA.
Intervention: We propose a multi-site, stepped wedge, cluster-randomized trial to determine the effect of a
physician-focused behavioral intervention on VHA prostate cancer imaging use. The multi-level intervention,
developed according to the Theoretical Determinants Framework, combines traditional physician behavior
change methods with novel methods of communication and data collection. The intervention consists of three
components: 1) a system of audit and feedback to clinicians informing individual clinicians and their sites about
how their behavior compares to their peers’ and to published guidelines 2) a program of academic detailing with
the goal to educate providers about prostate cancer imaging, and 3) a CPRS Clinical Order Check for potentially
inappropriate imaging. The intervention will be introduced to 10 participating geographically-distributed study
sites.
Analysis Plan: We will assess imaging rates 6 months prior to the intervention and 3 months following the
intervention. The study’s specific aims seek to understand the effects of the intervention on 1) facility-level
prostate cancer imaging rates, 2) physician experience with and perceptions of the intervention and its
implementation, and 3) the costs of both implementing the intervention and affecting change in imaging use.
These aims will support a subsequent intervention to improve guideline-concordant imaging across VHA.
Experience gained through this project will be leveraged to improve guideline-concordant care and increase
operational effectiveness in other domains.
Importance: This project seeks to describe and analyze the implementation of a behavioral intervention to
improve prostate cancer care. This theory-based intervention builds on prior work identifying barriers to
guideline-concordant prostate cancer imaging in VHA (CDA 11-257) and addresses these at three levels:
individual (audit and feedback with VHA Cancer Care Cube data), facility (academic detailing) and system (CPRS
Order Check). The team will assess the intervention’s cost impact and providers’ experiences in preparation for a
subsequent large -scale VHA implementation project optimizing the operational effectiveness of prostate cancer
imaging across VHA. The current application is an opportunity to leverage VHA’s state-of-the-art, integrated
healthcare delivery system to implement a carefully designed, theory-based behavioral intervention to reduce
harmful, inappropriate care, increase appropriate care to those who truly need it, and simultaneously save money
for the healthcare system.

Public health relevance
The goal of the current project is to improve prostate cancer imaging for Veterans with newly- diagnosed disease. We will determine the effects of a multi-site, physician-focused behavioral intervention on prostate cancer imaging. The intervention consists of three components: 1) audit and feedback 2) academic detailing and 3) a CPRS Clinical Order Check. We will implement the intervention among 10 participating clinical sites geographically distributed across the U.S. Analysis will focus on rates of imaging and their concordance with guidelines, as well as qualitative data concerning perceptions of the intervention and cost data around implementation and change in behavior. The current application is an opportunity to leverage VHA’s state-of-the-art, integrated healthcare delivery system to implement a carefully designed, theory-based behavioral intervention to reduce harmful, inappropriate care, increase appropriate care to those who truly need it, and simultaneously save money for the healthcare system.